Role of molecular recognition in retinal patterning and synaptic organization

ABSTRACT: Candidate and Environment: Dr. Peter Fuerst will conduct the research contained within this proposal at Washington State University. Washington State University is an ideal environment in which to conduct advanced biomedical research using mouse models and in which to advance a research program. Research Proposal: The research we propose will use mouse models to identify the molecular mechanisms underpinning development of the retina. The mouse models, all developed by the applicant, include a conditional allele of the Down syndrome cell adhesion molecule, Dscam, as well as an allelic series of mouse mutant Dscam strains and a null allele of the Dscam homologue Dscam-like1 (Dscaml1). Dscam and Dscam- Like1 are essential for normal development of the nervous system and Dscam is proposed to contribute to the pathology of Down syndrome. In the retina, Dscam is required for soma mosaic spacing, regulation of cell number and neurite arborization and lamination. Our published results concerning Dscam and Dscaml1 are the first demonstrations of mutations found to ablate mosaic patterning and the first genes shown to mediate isoneuronal and heteroneuronal repulsion in vertebrates. Specific Aims: We propose to use the Dscam and Dscaml1 mutant mouse models to discover mechanisms underpinning development of the retina and to probe the function of Dscam in the mammalian nervous system. This will be accomplished by testing the following hypotheses detailed in this research proposal. Hypotheses: 1) We will test the hypothesis that DSCAM mediates multiple distinct functions using an allelic series and conditional allele of Dscam mouse mutant lines to genetically and temporally isolate Dscam-dependent developmental processes. 2) We will test the hypothesis that DSCAM mediates adhesion between cell types and repulsion within cell types and that DSCAM activity in the retina is mediated by homophillic interactions and not by a ligand-receptor mechanism by using a conditional allele coupled to cell type specific deletion. 3) We will test the hypothesis that Dscam and Dscaml1 regulate normal developmental cell death. Long-term goals: This research will uncover fundamental aspects of neural organization and provide the funding necessary for Dr. Fuerst to establish a successful academic career focused on hypothesis driven biomedical research. Significance: Neurite arborization, regulation of cell number and soma mosaic spacing are fundamental aspects of neurodevelopment that are not currently well understood at the molecular level in vertebrates. Our preliminary research indicates that DSCAM plays a vital role in mediating these processes in the mammalian nervous system. Identifying mechanisms by which DSCAM functions using a series of mouse mutant alleles and a conditional allele will contribute to our understanding of nervous system development and the causation of disorders associated with neural dysgenesis and also contribute valuable research models to the neuroscience community.

Public health relevance
Project Narrative The primary goal of the proposed work is to understand how molecular recognition cues facilitate neural patterning. Research will focus on discovering the mechanisms by which two recognition cues; the Down Syndrome Cell Adhesion Molecule (Dscam) and its homologue Dscam-like1 (Dscaml1), mediate circuit formation within the retina. Both Dscam and Dscaml1 are required for neurite lamination, neurite arborization and regulation of cell number. Therefore, understanding the mechanism by which these molecules function will advance scientific understanding of neural development on multiple fronts. Furthermore, decreasing Dscam dosage decreases the incidence of retinal developmental cell death suggesting that the retina may provide an excellent system in which to model enhanced developmental cell death of neurons that occurs in Down syndrome patients, who overexpress Dscam as a result of Chromosome 21 trisomy. __SpecificAimsTextDelimiter__ A) Specific aims Development of the retina requires the coordination of multiple highly complex processes including neurite arborization and synaptic integration. The differential adhesion hypothesis posits that cell adhesion molecules provide recognition cues that are required for regulation of these processes. The unknown identity of such cues has impeded scientific understanding of retinal development. Recent identification of two recognition cues, the Down Syndrome Cell Adhesion Molecule (Dscam), and its homologue Dscam-like1 (Dscaml1), will facilitate discovery of mechanisms by which the retina is patterned. Dscam and Dscaml1 (Dscams) are homophilic cell adhesion molecules that facilitate self-recognition within single neurons during neurite arborization, within cell types during mosaic soma spacing and between cell types during synaptic pairing. DSCAM can also act as a ligand for the axon guidance molecule netrin. In the chick retina, Dscams are required and instructive for synaptic lamination of neurites. In the mouse retina Dscam is required for neurite arborization, regulation of cell number and soma mosaic spacing of several amacrine cell types and all assayed retinal ganglion cell (RGC) types, while Dscaml1 functions in a similar manner in A2 amacrine cells and rod bipolar cells. Unlike Drosophila Dscam1, which has thousands of verified splice isoforms to provide molecular diversity, vertebrate Dscams do not undergo extensive alternate splicing. This raises the question of how relatively simple genes can facilitate such a wide range of crucial developmental processes in a large number of distinct cell types. One hypothesis is that vertebrate DSCAMs act primarily through adhesion as part of a larger adhesion code that provides the diversity of recognition cues required to pattern the nervous system. A second hypothesis is that vertebrate DSCAMs act primarily through repulsion to prevent the adhesion of other molecules that act as cell type specific identifiers. Alternatively, DSCAMs may act through both adhesion and repulsion in different cell types or at different developmental stages or may have divergent functions in chick and mouse retina. The long-term goal of this project is to discover mechanisms by which molecular recognition cues pattern the retina. A unique set of mouse genetic resources including an allelic series and conditional allele of Dscam and a null allele of Dscaml1, all developed by the applicant, will be employed to test the following hypotheses: Aim 1. Test the hypothesis that Dscam has discreet functions that occur in a temporal fashion: DSCAMs are reported to act in different processes during retinal development in different species. To test the hypothesis that DSCAM has multiple distinct functions that are temporally regulated we will: A. Utilize an allelic series to genetically isolate different Dscam-dependent developmental processes. B. Delete Dscam at different developmental time points to test the hypothesis that Dscam has different functions with respect to adhesion and repulsion at different developmental stages. Aim 2. Test the hypothesis that DSCAM acts through adhesion between synaptic partners during neurite lamination and through repulsion within cell types during neurite arborization. DSCAM is proposed to act as a homophilic adhesion molecule, to facilitate both repulsion and adhesion. DSCAM can also act as a receptor for the ligand netrin, to mediate axon guidance. A conditional allele of Dscam will be used to test the cell autonomy of Dscam by conducting the following experiments: A. Delete Dscam from either amacrine or retinal ganglion cells (RGCs) and assay the resulting phenotype in both the deleted cell types and their synaptic partners to test the hypothesis that Dscam acts between cell types during lamination and within cell types during arborization and soma spacing. B. Delete Dscam from a subset of cells within cell types to test the hypothesis that DSCAM dependent arborization and soma spacing is mediated through repulsion, and not a ligand-receptor mechanism. Aim 3. Test the hypothesis that developmental cell death is impaired in the absence of Dscams: Neurons that normally express Dscam or Dscaml1 are overabundant in the absence of either respective gene. RGC number is indistinguishable in Dscam null and wild type retinas at birth, but is subsequently higher in the Dscam null retina until eye opening. Shortly after eye opening Dscam null RGCs show signs of stress and decrease in number. To test the hypothesis that DSCAMs regulate normal developmental cell death we will: A. Assay the incidence of cell death in wild type, Dscam or Dscaml1 null and heterozygous retinas. B. Test the hypothesis that RGC stress observed in the Dscam null retina is dependent on light mediated visual activity by assaying markers of stress after monocular or binocular light deprivation. Dscam and Dscaml1 are the first identified genes that are required for mosaic soma spacing and also mediate neurite lamination, neurite arborization and cell number. Understanding the mechanism by which these genes function will advance scientific understanding of multiple key aspects of retinal development.